Center for Integrated Biomedical and Rural Health Research

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The overall goal of the Administrative Core (Core A) of this Center of Biomedical Research Excellence (COBRE) application is to provide the leadership, services, coordination and tools necessary for the success of Research Project Leaders (RPLs), Core Directors, Pilot Project Investigators (PPIs), the External Advisory Council (EAC), Internal Mentoring Council (IMC) members, and collaborators. We seek to accomplish our overall goal via four specific aims to provide: 1) Administrative leadership, services, and tools to support career development and expansion of the community of researchers in integrated biomedical and rural health research, 2) administrative infrastructure for the recruitment of additional faculty, 3) administrative support, services and oversight to the Gene Editing and Mouse Models Assessment (GEMMA) Research Core, and 4) leadership and support for evaluation and other services, as needed, to ensure successful day-to-day functioning. The Administrative Core is significant in that it will drive development and attainment of the overall COBRE timeline and milestones for success, support development and implementation of Career Guidance Plans, oversee the progress of the COBRE’s four initial research projects, identify and support replacement research projects, direct the Pilot Project Program, provide continual evaluation of projects, mentors, core leaders and administration, and develop and implement the COBRE’s Sustainability Plan through which we can effectively transition from COBRE phase I to COBRE II and III phases with a diversified, sustainable and applicable post-COBRE funding model. The Administrative Core is innovative in providing continual opportunities for growth through on-the-job experience and educational enhancement, in fostering a close working relationship between scientists, administration and the community, in promoting the intrinsic sense of individual and collective ownership of problems and solutions, and in innovative mentoring and partnership with the first physician medical education organization in Montana and the largest comprehensive healthcare system in central Montana. To ensure success of the component parts and the COBRE overall, we engage in ongoing comprehensive evaluation. In short, the Administrative Core is responsible for directing the launch, day-to-day activities, and sustained success of this CoBRE center in order to expand and enhance biomedical research across Montana and our region.

Public health relevance
Overall Plan: Narrative The goal of this application is to establish the Center for Integrated Biomedical and Rural Health Research (CIB- RHR), a Center of Biomedical Research Excellence (CoBRE), that will enhance research infrastructure in a unique geographical, socio-cultural and economic region of the Rocky Mountain front and adjacent plains. The application is significant as it serves the two primary purposes of increasing the cohort of NIH funded investigators and of advancing our understanding of common health conditions of special concern and/or prevalence in a rural environment. The application is innovative in that the Center will provide unprecedented opportunities for talent recruitment and innovation in a rural underserved region of the United States, will establish the physical and intellectual presence required to increase trust in biomedical research in rural communities, and will serve as a potential model for other rural communities.